Mayo Clinic Ovarian Cancer SPORE

PROJECT SUMMARY – OVERALL
This revised application of the Mayo Clinic SPORE in Ovarian Cancer (OC) builds on translational research con-
ducted during Years 6-10 of funding. Our accomplishments over the past five years include i) identification of a
unique vaccine strategy that, in a phase I study, led to 39% recurrence free survival at 49 months in high grade
serous OC, ii) new understanding of the genomic and biochemical changes that limit the action of PARP
inhibitors (PARPis) in OC, iii) distribution of over 9600 biospecimens for OC research, and iv) publication of 220
articles. The Developmental Research Program (DRP) has contributed to two of the four projects in this renewal;
and the Career Enhancement Program (CEP) contributed to leadership of two projects. The overall goal of the
SPORE remains to support innovative, interactive, translational OC research that leverages the expertise of bas-
ic and translational investigators. This renewal contains four translational projects designed to investigate OC
biology and enhance therapeutic response, building on recent clinical advances and promising preclinical results:
• P1 (Development of a Th17-Inducing Dendritic Cell [DC] Vaccine for OC): Based on our study showing that
DCs pulsed with Folate Receptor α peptides and matured to a Th17-inducing phenotype induced immune re-
sponses in all patients and long-term recurrence-free survival in 39%, we will identify determinants of long-
term vaccine response in a phase II trial and elucidate mechanisms of immune escape from this vaccine.
· P2 (Next Generation TOP1 Inhibition for the Treatment of OC): Building on our observation that TOP1 inhib-
itors are active in PARPi-resistant OC models and this activity can be enhanced by PARPi treatment even in
the face of PARPi resistance, this project will identify determinants of sensitivity to TOP1 inhibitor/PARPi
combinations and conduct a phase II trial of the ultra-long acting TOP1i PLX038 with the PARPi rucaparib.
· P3 (Repurposing Ceritinib for OC Therapy): Based on the finding that ceritinib, a kinase inhibitor used for ALK-
rearranged lung cancer, inhibits mitochondrial respiration, increases reactive oxygen species, and sensitizes
OC cell lines and PDXs to PARPis independent of ALK status, we will identify pathways that mediate these
effects and conduct a phase I trial of the ceritinib/olaparib combination.
· P4 (Treatment of Advanced OC Using Gene-Edited CAR NK Cells): Building on a prior developmental research
project, this team located at the University of Minnesota will apply advanced cellular engineering techniques
to generate activated NK cells with enhanced tumor homing and persistence, then test the safety and efficacy
of administering this allogeneic adoptive immunotherapy in a phase I clinical trial in platinum-resistant OC.
These impactful projects are supported by four highly interactive cores: Core A (Administrative), Core B (Biospec-
imens/Patient Registry), Core C (Biostatistics/Bioinformatics) and Core D (Animal Models). A DRP and CEP will
be used to nurture the next generation of translational OC investigators. Collectively, these SPORE activities will
provide new insight into OC biology while examining potential therapeutic advances for this lethal disease.

Public health relevance
NARRATIVE – OVERALL With an estimated 22,000 new cases and 14,000 deaths each year, cancer of the ovary, fallopian tube or peritoneum (termed “ovarian cancer” in this application) remains the most lethal of the gynecological malignancies. The Mayo Clinic SPORE in Ovarian Cancer provides support for translational research projects that are intended to have a rapid impact for ovarian cancer patients. Specifically, we will develop and test four novel therapeutic approaches designed to i) stimulate the immune system (Project 1), ii) introduce a Next Generation TOP1 inhibitor for ovarian cancer (Project 2), iii) repurpose the FDA-approved kinase inhibitor ceritinib as an ovarian cancer therapeutic (Project 3) and iv) provide a new form of adoptive immune cell therapy (Project 4).